BLRD Research Career Scientist Award Application

To ensure aging Veterans remain active and mobile with as little musculoskeletal pain as possible, new
approaches to the prevention of osteoporosis and promotion of timely bone regeneration following a fracture are
necessary. This collaborative research study brings together a group of VA investigators with diverse
perspectives, insights, models, and techniques, to synergistically attack a major clinical problem that leads to
high morbidity and mortality among Veterans, a bone fracture. The overall research strategy of each integrated
project is to use pre-clinical models of a disease that either weakens bone or delays bone repair, to investigate
novel ways to enhance the ability of parathyroid hormone (PTH) to promote bone formation, and to assess
disease and treatment effects on bone in a unified, stringent manner. Already under-diagnosed and under-
treated, osteoporosis is likely to increase the number of fragility fractures being treated at VA hospitals without
novel tools for early detection and novel treatment strategies that circumvent the rare but devastating side effects
of current therapies that inhibit bone loss. Addressing this unmet clinical need, the overall aims are to identify
therapeutic strategies to improve bone health among Veterans and to enhance the bone anabolism of PTH
signaling. The collaboration will address this overarching hypothesis: health problems disproportionately
affecting Veterans activate signaling pathways that increase bone resorption, suppress bone formation, or
impede the transition of cartilage to bone in a fracture callus such that improvements in the clinical management
of osteoporosis lie in understanding how these health problems hurt bone health.
This project entitled “PTH receptor Signaling and Diabetes-Induced Bone Disease” will test the hypothesis that
that diabetes (DM) triggers Nox-mediated ROS distress and cholesterol accumulation in bone, which impact
bone formation and material properties; and that these effects are reversed by activation of the PTH Receptor
(PTH1R)/SIK axis in osteocytes. This hypothesis will be tested using a preclinical model of established DM,
bones from diabetic patients, FDA-approved PTH1R ligands PTH and ABL, the orally available SK-124 inhibitor,
and molecular, cellular, and tissue level advanced approaches. Aim 1 will establish the contribution of Nox/ROS
distress and cellular cholesterol accumulation to DM bone disease. We will determine whether DM-induced bone
disease is prevented 1a) by interfering with p22phox-Nox-mediated ROS in mice with loss of function of the
CYBA gene/p22phox protein and/or 1b) by increasing ABCA1-mediated cholesterol efflux pharmacologically with
the liver X receptor (LXR) agonist GW3965. Aim 2 will identify the target cell(s) in bone mediating the crosstalk
between DM and PTH1R/SIK axis. We will establish cell population profiles, gene expression, and
function/pathway enrichment analysis in bone and bone marrow cells, separately, by single cell RNA sequencing
(scRNAseq). Results will be validated by quantification of targeted gene ex-pression (NanoString) and tissue-
spatial transcriptomics (GeoMx). We will use bones from DM mice treated with PTH, ABL, or SK-124; and from
diabetic patients and control individuals subjected to hip replacement. Aim 3 will determine the role of osteocytes
in the restoration of bone material properties by the PTH1R/SIK axis in DM. We will investigate if osteocytes are
needed in vivo for PTH/ABL/SK-124 to correct the deteriorated bone matrix properties induced by DM, including
changes in bound water, Glycosaminoglycans (GAGs) composition, and Advance Glycosylation End Products
(AGEs), using osteocytic PTH1R knockout mice. Aims 1-3 and Aim 2 will be supported by the Bone Quality Core
and the Molecular Biology and Histology Core of the FRACTURE CURVE, respectively. Successful completion
of the proposed studies will reveal novel genes, pathways, and cells to be therapeutically targeted downstream
of the PTH1R signaling pathway to restore skeletal health in the frame of DM.

Public health relevance
This proposal addresses a significant health problem globally and in the US Veteran community, which is the bone disease induced by diabetes (DM). The American Diabetes Association declared this disease a nationwide epidemic. Within the general population, 1 year after suffering a hip fracture, 25% of patients will die, 30% will suffer a permanent disability, and 40% will be unable to walk independently. Diabetic patients exhibit >30% in- crease in bone fracture risk compared to non-diabetics. Thus, morbidity and mortality due to bone fractures is significantly augmented in DM. Successful completion of the proposed studies will reveal novel genes, pathways, and cells to be therapeutically targeted downstream of the PTH1R signaling pathway to restore skeletal health in the frame of DM.